Synergy-R Diffractometer for Southeastern Wisconsin

Abstract
We request funds to purchase a new single-crystal X-ray diffractometer (scXRD) equipped with a Cu-anode
rotating source, VariMaxHF computer-controlled optics and a hybrid photon counting detector. This equipment
will be installed in the Department of Biochemistry at the Medical College of Wisconsin (MCW) as a shared
resource. The department has a long history of supporting macromolecular crystallography dating back to
1992. The requested equipment will replace an outdated 18-year-old diffractometer that has been a workhorse
for the collection of macromolecular X-ray diffraction data by numerous NIH-funded investigators. Structural
biology has long been a cornerstone for a diverse group of NIH-funded researchers at MCW and in
southeastern Wisconsin. This is demonstrated by the continued support of the Biomolecular NMR Facility (Est.
2000), the formation of the Program in Chemical Biology (PCB) in 2017, and the acquisition of a Thermo
Glacios cryo-EM installing on MCW’s campus in 2023. The continued expansion of drug discovery on campus
has recently benefited from over a $5M investment in infrastructure and the commitment to hire 2 to 3 tenure-
track faculty into the PCB. Additionally, the Department of Biochemistry has hired two structural biologists
within the past four years. Consistent with a 30-year track record of supporting scXRD systems, MCW has
committed space to house the requested system, funds for service contracts/consumables, and salary support
for technical staff to ensure training of the users. We describe projects for six major users with NIH-funding and
ten minor users (seven with NIH-funding). These user projects aim to understand a wide range of human
diseases: cancer, psychiatric disorders such as Parkinson’s, ischemia, viral infectivity by cytomegalovirus and
coronavirus, obesity, and non-alcoholic fatty-acid liver disease. Many of these projects involve developing
small molecules for future therapeutics. The proteins are as diverse (soluble, transmembrane, integral
membrane) as their functions and require an scXRD capable of handling this diversity. The requested system
from Rigaku has the versatility to handle these projects. These researchers will rely on its increased sensitivity
and the ability to collect data directly from crystallization trays. Our user group will also benefit from this
instrument's ability to determine the absolute configuration of small molecules, a capability lacking in the local
community. When installed, the requested diffractometer will be the only one in Wisconsin and one of less than
five installed at academic institutions in the United States. A staff with more than 18 years of experience in X-
ray crystallography and 10 years of experience operating and maintaining scXRD instrumentation will oversee
the new system. Users will be trained in the operation of this system, and instrument time will be allocated
using a web-based scheduling system. An advisory committee will provide oversight of operations and conflict
resolution. Acquisition of the scXRD system requested in this S10 application will significantly accelerate NIH-
funded biomedical research programs at MCW and other institutions in the region.

Public health relevance
Project Narrative As a nationally prominent freestanding medical school, the Medical College of Wisconsin is committed to enhancing and maintaining a regional structural biology resource to support NIH-funded critical research programs in inflammation, infectious diseases, cancer, kidney diseases, diabetes, digestive diseases, and cardiovascular disease. This proposal is to replace an obsolete single-crystal X-ray diffractometer housed at the Medical College of Wisconsin. The new state-of-the-art instrument will enhance the ability of researchers in Southeastern Wisconsin to determine structures of medically relevant proteins, driving biological discoveries and enabling the development of new therapies.